Adult Changes in Thought (ACT) Research Program Core E: Neuroimaging Core

CORE E: ACT NEUROIMAGING CORE Summary/Abstract
The Neuroimaging Core provides the technical and analytic expertise to elucidate interactions between the
complex neurobiological aging processes studied across all U19 Projects and Cores. The Aims of the core
include collection and analysis of new MRI scans, collection and analysis of post-mortem high resolution ex
vivo brain MRI scans for alignment with the excised brain tissue, examination of image-guided tissue sampling
to supplement neuropathological analysis, and the application of machine learning and artificial intelligence (AI)
techniques to enhance imaging data collected in ACT participants that will support the Projects and other cores
in the ACT U19 Program. The Neuroimaging Core will leverage data science techniques and apply rigorous
methods to analyze how longitudinal imaging data collected from ACT participants interact with related clinical,
genetic, neuropathological, laboratory, and pharmacy information. The Neuroimaging Core will create synergy
within the Program by contributing data and providing imaging analyses to the Projects, helping to integrate the
Program through close collaboration with the other Cores especially the Neuropathology and Data and
Analysis Cores, and will work as a conduit for sharing knowledge and ideas as they arise in the Program, all
of which helps the ACT U19 Program accomplish more than the individual Projects could achieve alone.